NUTRITION-RELATED CHANGES IN PATIENTS UNDERGOING TUMOR NECROSIS FACTOR THERAPY

This study attempts to document and describe changes in nutrition-related parameters, specifically: (1) changes in body weight and percent body fat; (2) changes in serum protein and albumin; (3) appetite status and dietary intake; (4) glucose and peptide hormone responses to meal stimulation before and after acute administration, during and following chronic therapy; (5) changes in LPL in patients undergoing therapy with tumor necrosis factor versus patients undergoing standard chemotherapy.